The National Drug Abuse Clinical Trials Network: New England Consortium Node

ABSTRACT This Administrative Supplement to the NIDA Clinical Trials Network: New England Consortium Node is to support three specific concepts: 1) Comprehensive Meta-Analysis of CTN Treatment Outcomes by Race and Sex This project will perform additional meta-analyses examining whether/how race and sex interact to predict likelihood of treatment success and likelihood of randomization into a CTN trial versus screen fail. Exploratory analysis will be conducted evaluating how these outcomes vary by ethnicity (i.e. Hispanic/Latinx). 2) Using Integrative Data Analysis to Examine the Impact of Psychosocial Treatments for Black Cocaine Users Enrolled in the CTN Using integrative data analysis of multiple CTN trials, this project will examine comparative effectiveness and moderators of substance use disorder treatments for Black substance users. 3) NIDA CTN Substance Use Disorder (SUD) Registry Initiative concept This project will establish a NIDA CTN Substance Use Disorder Registry to allow investigators to follow substance users over time.

Public health relevance
Project Narrative This Administrative Supplement to the NIDA Clinical Trials Network: New England Consortium Node is to support three specific concepts 1) Comprehensive Meta-Analysis of CTN Treatment Outcomes by Race and Sex; 2) Using Integrative Data Analysis to Examine the Impact of Psychosocial Treatments for Black Cocaine Users Enrolled in the CTN, and 3) NIDA CTN Substance Use Disorder (SUD) Registry Initiative concept